Genetic Studies of Large Palindromes

Abstract
Arrays of large, nearly identical, palindromic DNA sequences in mammals are rare in the genome. What benefit
large palindrome arrays have to the genome, or an organism remains unclear. A few studies of large palindrome
arrays on the mouse X and Y chromosomes reveal they can result in selfish chromosome transmission and be
necessary for male fertility. Due to the large megabase size, high levels of nucleotide identity between
palindrome arms, and multicopy nature, large palindrome arrays have been challenging to resolve and study
experimentally. Moreover, our understanding of large palindrome arrays on autosomes is largely nonexistent.
Here, we propose to overcome these barriers by using recent haplotype-resolved genome assemblies to identify,
genome-wide, and comprehensively characterize seven of the 14 large palindrome arrays in mice. We
hypothesize large palindrome arrays evolve to favor their own inheritance and are necessary for fertility. We will
test our hypothesis via two aims. Aim 1 will determine whether two autosomal large palindrome arrays contribute
to selfish chromosome transmission when heterozygous and are necessary for fertility when homozygous. Aim
2 will determine whether the five large palindrome arrays on the X chromosome cooperate or compete to
influence selfish chromosome transmission or fertility. The simultaneous characterization of large palindrome
arrays on autosomes and the sex chromosomes can provide a unifying view of palindrome arrays in selfish
chromosome transmission and necessity in fertility. Our studies will enable new studies of these largely
overlooked genomic regions and their associated genes in all species, including humans. Our research efforts
will provide the foundation for mechanistic insights into their associated genes’ roles in influencing fertility,
chromosome evolution, and speciation.

Public health relevance
Relevance: The benefits of large palindrome arrays in the genome remain largely unknown. By characterizing their necessity in the germline, we will understand their benefits to the germline, genome, and organism.